BAF - SR Component

BIOMOLECULAR ANALYSIS FACILITY – PROJECT SUMMARY
The Biomolecular Analysis Facility (BAF) provides a centralized setting for a diverse suite of services and
instrumentation in the `omics' (genomics, transcriptomics, proteomics, lipidomics, metabolomics) and molecular
interaction and provides comprehensive bioinformatics support services such as pipelines and data analysis
tools. The facility is divided into sections that interact and support each other – Proteomics, Genomic Sciences,
Lipidomics/Metabolomics, Shared Instrumentation, and Bioinformatics. The resource serves University of
Virginia Cancer Center (UVACC) Members by providing expertise in experimental design, sample processing,
cost-effective data collection, data analysis, and support for manuscripts and grants. UVACC investigators
have access locally to a wide variety of services that can determine qualitative and quantitative changes at the
cellular level, including Next Generation Sequencing, including bulk DNA/RNA-Seq, Single cell/nuclei RNA and
ATAC-seq, third generation long-read sequencing, quantitative gene expression, genotyping, complex protein
mixtures, biomarker profiling, post-translational modifications, molecular interactions and kinetics, lipids,
metabolites, and drug analysis. The consolidated organization of the facility allows UVACC Members to
perform many of these experiments on the same or related samples. One key area of focus within the BAF is
providing access to advanced instrumentation and experiments that meet UVACC needs. Within the past two
years, the facility added two mass spectrometers in the areas of proteomics and metabolomics and two higher
capacity NGS instruments. As the majority of BAF users are UVACC Members, the interaction with these
investigators is the driving force for acquiring new instrumentation and developing new techniques. The
UVACC Executive Committee and Office of Research Core Administration (ORCA – within School of Medicine
(SOM) Dean's Office) work closely together to foster this environment. To that end, the SOM provides direct
budget support to the BAF every year (~30% total budget), which together with the UVACC co-pay, provides
UVACC Members with highly effective services at remarkably competitive prices.

Public health relevance
Project Narrative: Per PAR-20-043, Project Narrative is not completed.